Regulation of Hepatic Phosphatidylcholine Synthesis by mTORC1

PROJECT SUMMARY
Non-alcoholic fatty liver disease (NAFLD) is a disease of altered lipid metabolism characterized by the
accumulation of fat in the liver. The prevalence of NAFLD is closely correlated with obesity, insulin resistance,
and type 2 diabetes mellitus. NALF can progress to a more severe form of liver disease, known as non-alcoholic
steatohepatitis, hallmarked by inflammation and fibrosis of the liver. Despite the severity of these diseases, there
are currently no FDA approved treatments for NAFLD and NASH, highlighting the critical need to elucidate the
mechanism underlying these diseases to develop new therapies. In the liver, the anabolic hormone insulin
regulates hepatic lipid homeostasis by promoting triacylglyceride (TAG) synthesis, suppressing fatty acid
breakdown, and promoting TAG export via very low-density lipoproteins (VLDL). VLDL-TAG secretion from the
liver is controlled by the biosynthesis of phosphatidylcholine (PC), the main phospholipid coating lipoproteins.
Defects in PC synthesis in human and rodent models are linked to decreased VLDL-TAG secretion and ultimately,
NAFL. Our lab recently demonstrated that downstream of insulin signaling in mice, the mechanistic target of
rapamycin complex 1 (mTORC1) controls VLDL-TAG secretion through regulation of CCTα, the rate-limiting
enzyme in PC synthesis. Therefore, the goals of this study are (1) to elucidate the relationship between mTORC1
and CCTα protein, and (2) to evaluate their subsequent control of hepatic phospholipid synthesis and lipid
homeostasis in vivo. Based on published phosphoproteomic studies, I hypothesize that mTORC1 directly
phosphorylates CCTα at Serine-315, and this phosphorylation prevents ubiquitination and subsequent
degradation of CCTα protein. In my preliminary data, I identify a mTORC1-dependent phosphorylation of CCTα
at Serine-315 as a critical step in controlling CCTα activity and this phosphorylation regulates total CCTα protein
content. Thus, I will test whether CCTα is directly phosphorylated by mTORC1 and establish the mechanism
through which mTORC1 regulates CCTα stability and activity. Furthermore, I will test the effects of CCTα
phosphorylation at Serine-315 in vivo, by utilizing adeno-associated virus constructs carry CCTα phosphorylation
mutants. On the basis of my preliminary data revealing CCTα phosphomimetic mutant at Ser315 (S315D) has
increased CCTα activity, I hypothesize that CCTα phosphomimetic mutant, S315D, enhances PC synthesis and
TAG secretion in vivo in mice. Lastly, I will test whether CCTα S315D mutant is sufficient to prevent NASH in
mice fed a high fat, low methionine, choline deficient diet, a commonly used NASH-inducing diet. Altogether,
findings from this study will identify a novel role of mTORC1 in regulating hepatic PC synthesis and TAG
secretion, which may be beneficial for the development of new therapies for NAFLD and NASH.

Public health relevance
PROJECT NARRATIVE The prevalence of non-alcoholic fatty liver disease (NAFLD) and non-alcoholic steatohepatitis (NASH) has increased in parallel with the global obesity epidemic, now affecting 25% of the world, and up to 75% of the obese and diabetic population. The mechanism of NAFLD pathogenesis is unknown but closely correlated with dysregulation of hepatic lipid metabolism, yet there are still no current FDA approved treatments for NAFLD and NASH. Therefore, this proposal aims to identify a novel role of the insulin pathway, in which the mammalian target of rapamycin complex 1 (mTORC1) controls hepatic phospholipid synthesis and hepatic lipid homeostasis, which will provide a unique mechanism to be exploited for future treatment of NAFLD and NASH.